Mount Sinai's CoFAR Clinical Research Center

Project Summary/Abstract
MOUNT SINAI’S CoFAR CLINICAL RESEARCH CENTER
Food allergy is estimated to affect approximately 8% of children and 10% of adults; in the US this translates to
32 million people. Food allergy is potentially life-threatening, significantly impacts quality of life and nutrition,
and carries a high economic burden. Although significant advances have been made for prevention and therapy,
prevalence rates remain high and therapeutic options are few. The long-term goals of CoFAR are to develop
effective strategies to prevent and treat food allergies, and to elucidate underlying mechanisms. As the
leadership center (LC) for CoFAR from 2005 to 2015, and as a CoFAR Clinical Research Center (CRC) for 17
years, we are the only CRC to have contributed to every CoFAR study, trial, and supplemental projects, with
leadership roles in 9 projects, including the current SUNBEAM birth cohort study. The objectives of CoFAR CRCs
is to conduct network-wide studies and trials and center-specific projects to advance knowledge, management
and treatment across a range of food-allergic diseases, and to elucidate underlying mechanisms. The Mount
Sinai CRC team has been successfully and safely conducting food allergy research since 1997. The CRC PI,
Scott Sicherer, MD, brings broad experience having been site PI for all of the past CoFAR interventional trials,
as well as being Protocol Chair of the CoFAR observational study and Co-Chair of SUNBEAM. Co-Investigators
Drs. Wang and Bunyavanich (who serves as chair for the SUNBEAM biosampling program) have served as
successful PIs on clinical trials. Early stage investigators on the team will benefit from their involvement to
become the next generation of leaders in food allergy research. Our CRC laboratories have been the central
biomarker facility for CoFAR and easily manage biological samples at the direction of the LC. The CRC is located
in Manhattan, with access to an extensive base of potential participants; it has safely conducted >30,000 oral
food challenges and has a superb record of study recruitment and retention. To increase opportunities to
contribute to CoFAR’s goals, a Network-wide clinical trial is proposed to improve safety and allow dietary
incorporation of common allergens; preliminary data suggest that potentially half of people living with IgE-
mediated food allergy may benefit. Two site-specific studies will inform improving diversity, equity and inclusion
in food allergy research, and inform pathogenesis and course of food allergy through a novel, non-invasive
approach. In summary, the Mount Sinai CoFAR CRC brings extensive resources and experience to ensure that
the goals of CoFAR, at the direction of the LC, Steering Committee and NIAID, are met.

Public health relevance
Project Narrative-Clinical Research Center The increasing number of Americans afflicted by food allergies has become a major public health problem and there remains inadequate preventative or therapeutic strategies. Mount Sinai’s Consortium for Food Allergy Research Clinical Research Center will perform site-specific projects, propose a Network-wide clinical trial to the Leadership Center, and participate in Network-wide studies selected by the Leadership Center and NIAID program officers to address this unmet health need. We will conduct novel and impactful clinical trials and studies and incorporate mechanistic studies to advance prevention and management strategies and to improve knowledge on the origins and immune basis of food allergy.